School based drug use prevention of girl athletes

Dr. Diane Elliot and associates are doing a study entitled "School-Based Drug Use Prevention for Girl Athletes". Subjects will be girls involved in a sports team at school. The purpose of this study is to 1) determine student's knowledge about the effects of weight loss/physique altering drug use, and unhealthy exercise and nutrition habits; 2) measure drug use, 3) gain information about nutrition and exercise habits among female students-athletes; and 4) understand factors that influence drug use and unhealthy eating and exercise habits.